Mechanism and regulation of DNA double-strand break repair

Chromosomal double strand breaks (DSBs) are cytotoxic lesions that occur spontaneously during normal cell
metabolism or following treatment of cells with DNA-damaging agents. If unrepaired or repaired inappropriately,
DSBs can lead to profoundly detrimental events, such as chromosome loss, deletions, duplications or
translocations. Defects in the repair of DSBs cause genomic instability, manifested as immunological,
development or neurological defects, and predisposition to cancer. The toxicity of DSBs is exploited for
radiation and chemotherapy, as well as targeted therapies directed against specific DNA repair proteins. Thus
understanding the mechanisms of DSB repair is of fundamental importance and has practical application for
development of new therapeutics and uncovering pathways to resistance. Typically, cells repair DSBs by either
homologous recombination (HR) or non-homologous end joining (NHEJ). HR employs extensive homology and
templated DNA synthesis to restore the broken chromosome and is considered to be an error-free process.
NHEJ directly ligates DSB ends, a mechanism that is potentially error prone due to small deletions or
insertions at the junctions. The choice between these two pathways is governed by the cell cycle, which
regulates an early step in HR, namely, 5'-3' resection of DSBs. The overall goal of our research program is to
decipher the mechanisms of homology-dependent DSB repair, using the yeast Saccharomyces cerevisiae as a
model system. The first part of our program builds on our previous studies showing that the conserved Mre11-
Rad50-Xrs2 (MRX) complex initiates 5'-3' resection. Specifically, we will use next-generation sequencing to
identify the sites of MRX nicking, determine how chromatin structure influences nick site selection and
measure the length of resection tracts in cells undergoing HR repair. In addition to controlling end resection,
MRX promotes NHEJ, tethers DSB ends and recruits the Tel1ATM kinase to DSBs to activate the DNA damage
checkpoint. We will determine the contribution of these diverse functions to genome integrity using specific
alleles of MRX components coupled to assays measuring gross chromosome rearrangements. DSBs that arise
by replication fork collapse or by erosion of uncapped telomeres have only one free end and are repaired by
strand invasion into a homologous duplex DNA followed by replication to the chromosome end (break-induced
replication, BIR). The second part of our research program utilizes physical and genetic assays developed in
my laboratory to address the mechanism and fidelity of DNA synthesis by BIR.

Public health relevance
The repair of DNA double-strand breaks (DSBs) is essential to maintain genome integrity and to guard against cancer in humans. We will use the yeast Saccharomyces cerevisiae as a model system to address the mechanisms of DSB repair; specifically, we will determine how the conserved MRN complex controls repair pathway choice and maintains genome integrity, and we will identify the mechanisms used to synthesize DNA during DSB repair. In the long term we believe that mechanisms under investigation in this proposal will provide new insight and fundamental knowledge for understanding disease caused by genomic instability.